Liver cancer risk and prevention among persons living with HIV/AIDS

DESCRIPTION (provided by applicant): Persons living with HIV/AIDS (PLWHA) have longer lifespans, thanks to antiretroviral treatment; however, the burden of non-AIDS-defining cancers, such as liver cancer, is increasing over time. The aging of this population, impaired immune function, and high prevalence of liver cancer risk factors hepatitis C virus, hepatitis B virus, an alcohol abuse and dependency contribute to the rising incidence of liver cancer among PLWHA. The purpose of the proposed study is to identify high-risk patients for the development of liver cancer and review the impact of liver cancer prevention methods in the population of PLWHA. Cancer diagnoses from the Veterans Affairs Central Cancer Registry will be linked with data from the Veterans Aging Cohort Study (VACS), a prospective, observational cohort of HIV-infected veterans in care in the United States. The VACS virtual cohort was established in 1996 and includes over 40,000 HIV-infected subjects and a sex-, age-, race-, and clinic site-matched cohort of HIV-uninfected veterans. Over 15 years of follow-up data on clinic visits and laboratory tests are available. FIB-4, an established marker of liver fibrosis and cirrhosis, is calculated from routine labs (alanine transaminase, aspartate transaminase, platelet count) and age. In PLWHA, a one-time measure of FIB-4 was strongly associated with subsequent development of liver cancer. The proposed work will investigate the effect of FIB-4 measured at multiple time points to see whether changes in FIB-4 are better able to predict liver cancer. This will be done with mixed-effects longitudinal regression models adjusting for known liver cancer risk factors and HIV-related risk factors. In addition to more efficient use of FIB-4 among PLWHA, additional analyses will be conducted in a cohort of HIV-uninfected subjects to determine if FIB-4's ability to identify high-risk patients differs by HIV status. After identifying high-risk patients for liver cancer, the focus then turns to prevention. While hepatitis B virus and hepatitis C virus treatment, prevention of weight gain, and hazardous alcohol consumption cessation are hypothesized to contribute to liver cancer prevention, it has not yet been quantified how the combination of prevention strategies impacts liver cancer prevention in PLWHA. Clinical biomarkers and measures of viral hepatitis treatment, obesity and weight, and diabetes control will be explored longitudinally in addition to biomarkers of liver function in a subset of high-risk HIV-infected subjects to assess the relative impact of these factors on liver cancer prevention and what will be most informative to clinicians and patients at high risk. The training component of this proposal will include: 1) advanced epidemiologic and statistical workshops, 2) seminars on HIV, cancer biology, and medicine, 3) shadowing of physicians to increase clinical knowledge and experience, 4) mentorship from two established epidemiologic researchers, and 5) collaboration with researchers in HIV and cancer epidemiology and biostatistics.

Public health relevance
PUBLIC HEALTH RELEVANCE: The burden of liver cancer and liver cancer mortality is growing in the United States, especially among persons living with HIV/AIDS. This research will identify patients at high risk for the development of liver cancer and provide prevention recommendations that can be easily applicable to patients receiving regular care for HIV. Accomplishing the aims will provide insight on clinical care and surveillance of high-risk patients for liver cancer and identification and quantification of liver cancer prevention methods for persons living with HIV/AIDS, a growing, but aging, population. __SpecificAimsTextDelimiter__ Specific Aims Combination antiretroviral therapy (ART) is attributed to increasing the life spans of persons living with HIV/AIDS (PLWHA)~ however, the aging population of PLWHA is facing the same chronic health problems as the general population.1 The burden of comorbidity and mortality is shifting, including increasing non-AIDS- defining cancer diagnoses over time.2 Due to the high prevalence of liver cancer risk factors such as hepatitis B and hepatitis C virus infections and likely hazardous alcohol use among PLWHA, liver cancer, specifically hepatocellular carcinoma, incidence is increasing.3 The purpose of the proposed study is to improve accuracy in the early identification of PLWHA who are at risk for the development of liver cancer and to identify approaches to liver cancer prevention. The study will utilize data from the Veterans Aging Cohort Study (VACS), a prospective, open observational cohort of HIV-infected veterans in medical care in the United States.4 Over 44,000 HIV-infected subjects and a 2:1 sex-, age-, race-, clinic site-matched cohort of HIV-uninfected veterans are followed. Over 15 years of data from national VA databases are available for subjects who enrolled as early as the cohort inception in 1996 through the present. Liver cancer diagnoses from the Veterans Affairs Central Cancer Registry will be linked to the VACS cohort. These data will be analyzed to achieve the following specific aims: Aim 1: Validate and optimize FIB-4 (a fibrosis biomarker) as an independent measure of liver cancer risk FIB-4 is an established marker of liver fibrosis and cirrhosis, calculated from platelet count, alanine transaminase, aspartate transaminase, and age.5 In a prior investigation, I determined that baseline FIB-4 is strongly associated with hepatocellular carcinoma development among PLWHA.6 Results from the following analyses in this aim will provide recommendations for FIB-4 use by clinicians and patients to identify patients at high-risk for liver cancer. Sub aim 1A: Explore longitudinal changes of FIB-4 to identify HIV patients at high-risk for liver cancer This investigation will determine the level of FIB-4 at different follow-up time points: baseline, one year post-baseline, at ART treatment initiation, one year post-ART initiation, and 5 years post-ART initiation. I then will evaluate the longitudinal trajectory using all available FIB-4 measurements in mixed effects regression models to predict liver cancer development. Regression models will adjust for HIV-related factors (HIV RNA level, CD4 cell count, ART) as well as liver cancer risk factors that may confound the relationship between FIB- 4 and the development of liver cancer. While the original baseline investigation was informative,6 it was a stepping-stone to more informative research on FIB-4 as a predictor of liver cancer. Sub aim 1B: Determine whether FIB-4 predicts liver cancer modified by HIV infection Explorations of FIB-4 and liver cancer in the HIV-uninfected population have not yet been conducted. Regression models will look at FIB-4 in both the HIV-infected and HIV-uninfected subjects in the VACS, adjusting for liver cancer risk factors and HIV. I hypothesize that there is multiplicative interaction between HIV infection and FIB-4 and the behavior of FIB-4 as a predictor of liver cancer depends on HIV-infection status. Since immunodeficiency increases the risk of liver cancer, there may be a synergistic multiplicative effect when a subject has both high FIB-4 and HIV. Aim 2: Identify the relative effectiveness of liver cancer prevention methods among PLWHA While treatment of hepatitis B virus, hepatitis C virus, and diabetes~ prevention of weight gain~ and cessation of hazardous alcohol consumption are all hypothesized to contribute to liver cancer prevention, the relative impact on liver cancer prevention has not yet been quantified among PLWHA. Furthermore, ART may play an important role in liver cancer prevention. Using a subset of HIV-infected subjects at high-risk for liver cancer defined by high FIB-4 level, hepatitis C virus infection, hepatitis B virus infection, alcohol abuse/dependency, or diagnosis of cirrhosis, this analysis will compare the contributions of these factors to liver cancer prevention among PLWHA. Measures of the hypothesized prevention methods will be tracked in relation to biomarkers of liver function longitudinally. I hypothesize that viral hepatitis treatment and ART will be the main drivers in liver cancer prevention. This investigation will be able to provide specific recommendations for liver cancer prevention to patients with different combinations of liver cancer risk factors. Accomplishing the aims above will provide insight and recommendations for the clinical care and surveillance of HIV-infected patients at high-risk for liver cancer and quantify liver cancer prevention methods for PLWHA, a growing population that is aging over time. The research plan proposed will result in a better understanding of the clinical course of disease and of how the effects of the above risk factors may contribute to changes in clinical management to prevent the development of liver cancer.